Sex-differences in HIV persistence and Immune Dynamics during Reproductive Aging

ABSTRACT
Background. Sex-based differences, largely controlled by sex hormones, affect the natural and treated history
of HIV infection and HIV-specific immune responses. Our previous work has shown that estrogen potently
represses HIV transcription, thus decreasing cellular HIV RNA in women compared to men. Unexpectedly,
women undergoing reproductive aging have a progressive increase in levels of inducible HIV reservoir, while
estrogen declines. This observed expansion of the reservoir as women age is in sharp contrast to the steady
decline in the reservoir size observed in men. Given the increasing number of women aging with HIV, it is critical
to determine the interplay of HIV persistence and declining sex hormones during reproductive aging to design
effective HIV cure strategies.
Our goal. Our study is specifically designed with samples from both cisgender men and women across the
reproductive aging spectrum. We will first define the impact of reproductive aging on multiple features of the
reservoir including size, transcriptional activity, along with a novel exploration of clonal expansion (Aim 1). Next,
we will precisely define the immunologic changes over the course of reproductive aging, using single cell
sequencing combined with immunophenotyping using DNA-barcoded antibodies (Aim 2). The data will be
integrated, and key features established using advanced statistical analyses.
Study Cohort: Longitudinal samples (viable cells, plasma), collected, processed, and stored using standardized
protocols in the multi-site Women's Interagency HIV Study (WIHS) and Multicenter AIDS Cohort Study (MACS)
cohorts will be utilized for all proposed experiments. First, we will carefully select 25 cisgender WWH on
suppressive combination antiretroviral therapy (ART) with biologic samples representing four reproductive
stages (reproductive/pre-menopause, menopausal transition/early and late perimenopause, post-menopause).
Then, we will identify 25 MWH as controls using a multivariate propensity score based matching algorithm. After
matching, stored samples collected between 2009 and 2019 will be selected based on similar time-intervals
across both groups.
How will we advance the field? To date, the majority of HIV cure research has used male participants and
therefore a significant knowledge gap exists between men and women. We do not know if the same immune-
modulatory interventions will be effective in promoting HIV RNA transcription in men and women and how
declining sex hormones will impact their efficacy. Agents that are designed for “kick and kill” strategies may be
impacted by estradiol-mediated mechanisms as women undergo reproductive aging. A better understanding of
these differences will assist in the design of future cure approaches that can be applied across sexes.

Public health relevance
Narrative There are distinct sex-based differences that affect the natural history and immune pathogenesis of HIV infection. These factors likely impact the establishment, distribution, and transcriptional activity of the HIV reservoir. Our study will determine the effect of declining sex hormones on HIV persistence and inflammation in midlife women during all stages of reproductive aging while on suppressive antiretroviral therapy and define underlying mechanism.